Role of IL-1alpha signaling in inflammatory diseases and host defense

ABSTRACT
Interleukin-1 (IL-1) family cytokines IL-1α and IL-1β, have emerged as principal mediators of multiple
inflammatory diseases. Both bind to the interleukin-1 receptor (IL-1R) to induce a proinflammatory signaling
cascade. Over the last decade, much progress has been made in defining the roles and regulation of IL-1β in
multiple disease models. Studies from our lab and others have highlighted the contributions of Nod-like
receptors (NLRs) and multi-protein complexes known as inflammasomes, and caspase-8 in the regulation of
IL-1β production and inflammation. In stark contrast to IL-1β, and despite being the first major human pyrogen
described, the regulation of IL-1α remains poorly understood. Notwithstanding the increasing appreciation of
the contribution of IL-1α in the pathogenesis of many important human diseases, the factors that control
functional IL-1α maturation remain completely obscure. Novel discoveries from our lab using a mouse model of
cutaneous inflammatory disease (Ptpn6spin mutant mice) suggest that the inflammatory disease progresses in
an inflammasome- and IL-1β-independent manner. Instead, inflammation in the Ptpn6spin model requires IL-
1α and is driven by receptor interacting protein kinase 1 (RIPK1). Except for these studies, our current
understanding of the roles and regulation of IL-1α in inflammatory disease is severely limited. The central goal
of this project is to identify the cellular and molecular mechanisms of IL-1α regulation and to provide critical
information essential for understanding the function of IL-1α.

Public health relevance
RELEVANCE STATEMENT Inflammatory diseases have been directly linked to IL-1α. However, we have little understanding of how IL-1α activity is regulated to induce IL-1RI signaling. Understanding the exact function and mechanism of IL-1α regulation will help in development of specific therapies that target IL-1α and potentially leave the beneficial roles of IL-1β intact. This proposal will fill the major gap in our understanding of IL-1α biological activity and will provide new mechanistic insights into fundamental processes related to IL-1α function, and have the potential to identify novel therapeutic targets to treat debilitating inflammatory diseases in humans.